Stanford Vision Research Core

SUMMARY - OVERALL
The Stanford vision research community is comprised of an impressive array of faculty bridging all levels
of vision research, from molecular to cellular to circuits to systems, from development to adult to disease. The
Stanford Vision Research Core grant will bring 4 modules to this community: (1) Advanced
Computing/Computational Core, (2) Device Design and Development, (3) Neurogenetics of Vision, and (4)
Imaging Structure and Function. These cores will be positioned to amplify the considerable resources Stanford
University is devoting to the growth of vision research, including new faculty recruiting in the Department of
Ophthalmology and the Stanford Neurosciences Institute and new space allocation to wet- and dry-lab vision
research, as well as commitments from the Department of Ophthalmology for additional administrative
capacities. Bringing these 4 cores to this community will help us achieve a number of specific outcomes. 1) We
will extend the reach of vision research among the NEI-funded investigators at Stanford: by providing core
resources and services to investigators, this grant will centralize specialty capacity, allowing faculty to benefit
from the ready availability of such expertise. 2) We will accelerate discoveries in these laboratories: the
availability of new resources that specifically target areas of need across the vision research community at
Stanford will allow research to move more quickly into new, cutting edge areas of innovation. 3) We will promote
inter-disciplinary collaboration that bridges molecular through systems level vision research: The selection of
these 4 cores also carries a specific intention to bring vision research at Stanford into a “next-generation” position
bridging across disciplines. Offering these tools, with cell- and species-compatible vectors, device development,
advanced imaging, and the computational power to extract relevant data from these, will facilitate this bridging.
Finally, 4) We will attract new faculty at junior through senior levels into vision research: by providing tools specific
to vision research, and making these tools available broadly to the Stanford research community, we will facilitate
entry into vision research by both seasoned investigators in other fields, and newly recruited junior investigators
poised to become the next generation of leaders in vision research.

Public health relevance
Stanford Vision Research Core NARRATIVE RELEVANCE This Stanford University Vision Research Core Grant will provide services and resources in four areas critical to extending the reach of vision research among the NEI-funded Stanford investigators, to accelerating discoveries in these laboratories, to promoting inter-disciplinary collaboration that bridges molecular through systems level vision research, and to attracting new faculty at junior through senior levels into vision research.